Nutrient-adaptive mechanisms driving mitochondrial lipid oxidation in response to fatty acid supply and demand

PROJECT SUMMARY/ABSTRACT
Nutrient fuel flexibility, the ability of mitochondria to switch oxidation fuel source for energy production, is a key
adaptation against fluctuations in nutrient supply. Adaptive resistance to lipid utilization has been linked to
diseases including diabetes, non-alcoholic fatty liver disease and cardiomyopathy but the mechanisms
underlying lipid (in)flexibility remain understudied. O-GlcNAcylation is a nutrient-sensitive protein modification
that is reversibly attached by the OGT enzyme and removed by OGA. Decreased OGA activity leads to a fuel
shift away from lipid oxidation in mice through an unknown mechanism. However, there is a lipid droplet-enriched
OGA isoform (sOGA) that is well-positioned to detect fatty acid supply/demand and to act on O-GlcNAcylated
targets through mitochondrial interactions or nuclear signaling pathways. Furthermore, a diabetogenic
polymorphism in the OGA gene was found near the splice junction, which regulates production of sOGA.
Recently in the lab, a metabolomics analysis of mouse tissue revealed a novel correlation between OGA loss
and acylcarnitine deficiency, a requisite metabolite pool in the uptake of long-chain fatty acids into mitochondria
through the carnitine shuttle. Therefore, the central hypothesis of this proposal is that OGA is required for the
upregulation of carnitine-dependent mitochondrial lipid oxidation and that sOGA, rather than the canonical lOGA,
is the predominant mediator. The goal of the research plan is to characterize OGA regulation of carnitine shuttle
flux through the modification of shuttle proteins (1), the supply of carnitine (2) and/or the nutrient-sensitive
transcription of critical proteins (3). All specific aims rely on germline OGA knockout (KO) mice/fibroblasts and/or
cells transfected with GFP- or HA-tagged sOGA or lOGA expressing plasmids as models. Aim 1 focuses on
sOGA modification of carnitine shuttle proteins using mitochondrial oxidation rate, immunofluorescent (IF)
imaging and OGA immunoprecipitation (IP) + mass spectrometry/western blot to evaluate nutrient fuel flexibility,
OGA/target co-localization and isoform-specific OGA targets. Aim 2 tests O-GlcNAc suppression of OCTN2
transporter-mediated carnitine uptake through qPCR/blotting for OCTN2 expression/protein, a tritiated
carnitine uptake assay and an OGA KO rescue attempt through in vivo carnitine supplementation. Aim 3 posits
PLIN5 deglycosylation is required for its phosphorylation, nuclear translocation and activation of
PPAR𝝰, a transcriptional regulator of carnitine homeostasis and lipid oxidation. This aim tracks PPAR𝝰 activity
using an in-house plasmid luciferase detector and IF, IP and blotting to characterize phospho-dead/mimetic and
O-GlcNAc-dead PLIN5 proteins, generated through site-directed mutagenesis.
Experiments will be conducted in the labs and core facilities of the NIDDK Laboratory of Cellular and Molecular
Biology under the sponsorship of Dr. John A. Hanover. The training plan supplements research activities with
teaching and leadership courses to facilitate the applicant’s career goal as an independent investigator.

Public health relevance
Cells require nutrients to make useable energy and many have evolved the flexibility to switch between glucose or lipids as a fuel source to adapt to fluctuations in nutrient supply. Improved lipid utilization underlies metabolic benefits of exercise and fasting while lipid inflexibility contributes to heart disease, non-alcoholic fatty liver disease, obesity, and type 2 diabetes. This proposal will progress our understanding of the mechanisms that couple nutrient environment to lipid utilization, providing needed insight into sources of toxic lipid accumulation and facilitating the development of therapies to improve metabolic health.